BLRD Research Career Scientist Award Application

Currently, the prevalence of diabetes in the VA patient population is approximately 25%, with many more
Veterans at risk for diabetes due to obesity, aging, and poor lifestyle, as well as exposure to known diabetogenic
chemicals in the line of duty. The number of Veterans with diabetes is certain to increase over the next decades.
Therefore, developing new methods for preventing diabetes and identifying and properly treating diabetic
patients is very timely and of great significance. Ongoing research in my laboratory is focused on two broad
areas: 1) understanding the molecular mechanisms controlling insulin secretion from the pancreatic beta-cell
and how these mechanisms are altered during the progression to type 2 diabetes (T2D), and 2) identifying
biomarkers associated with beta-cell dysfunction in T2D.
For over two decades, the focus of my research program has been elucidating the role of prostaglandin EP3
receptor (EP3), and its associated G protein, Gz, in regulating beta-cell function, proliferation, and survival. In
Specific Aim 1 of my current BLR&D Merit Review Award, we are testing the hypothesis that loss of the catalytic
alpha subunit of Gz, Gɑz, protects mice from T2D due to increased signaling through cholecystokinin A receptor
(CCKAR). The research proposed in this aim is built off a long-standing and productive collaboration with Dr.
Dawn Belt Davis, a VA-funded physician-scientist whose expertise is in understanding the islet autocrine and
paracrine signaling pathways controlling beta-cell function and mass. In Specific Aim 2a of my current BLR&D
Merit Review Award, we are elucidating the specific molecular mechanisms downstream of mouse and human
EP3 splice variants in whole islets, correlating signaling changes with downstream effects on beta-cell function,
proliferation, and survival. This research is being performed in collaboration with Dr. Matthew Merrins, a VA-
funded investigator who uses innovative biosensors and molecular probes to study beta-cell metabolic and signal
transduction processes. Our hypothesis is EP3 signals by Gɑz-dependent and -independent mechanisms, and
that these mechanisms differ based on whether an EP3 splice variant is constitutively active vs. agonist
stimulated. Finally, the native ligand for EP3 is prostaglandin E2, an arachidonic acid metabolite. Specific Aim 2b
applies an innovative, high-throughput, ultrahigh resolution mass spectrometric approach for untargeted
metabolomics, developed in collaboration with the highly accomplished analytical chemist Dr. Ying Ge, to islet
lysates obtained from mice and human organ donors, correlating changes in the arachidonic acid metabolome
during the progression to T2D with downstream effects on β-cell function, proliferation, and survival. Finally, a
recent R01 application selected for funding complements and expands on these aims.
During the Research Career Scientist (RCS) Award period, I will continue our currently funded research while
simultaneously translating our findings into the clinical direction. First, our research into the molecular
mechanisms of EP3/Gɑz signaling will further validate their potential as new T2D therapeutic targets and
elucidate ways in which to block their signaling. Within the next five years, we also anticipate identifying a small
molecule that selectively interferes with Gɑz’s interaction with constitutively active EP3 splice variants, relieving
their inhibition on beta-cell second messenger signaling and downstream beta-cell function and mass. In parallel,
will work with collaborators at UW Madison and the Medical College of Wisconsin to test methods to specifically
target an EP3 antagonist and/or Gɑz antisense oligonucleotide specifically to the beta-cell. Finally, using the
results of our metabolomics analysis, we will identify a small panel of metabolites significantly and independently
associated with beta-cell dysfunction, testing whether the levels of these metabolites predict the responsiveness
of VA patients failing metformin monotherapy to two gold-standard classes of T2D drugs. Finally, the Research
Career Scientist Award support will allow us to collect the critical additional data to support my next round of
Merit Review application.

Public health relevance
Diabetes is a costly and complex chronic illness and a serious public health problem, responsible for a host of complications that significantly decrease healthy lifespan. The Veteran population has a significantly increased prevalence of diabetes as compared to the general population, making diabetes a critical problem in Veterans’ health. The underlying issue in diabetes is the failure of the pancreas cells to release enough of the hormone, insulin, into the bloodstream to properly control blood sugar levels. The aims of my research program are to characterize emerging cellular targets to promote pancreatic cell health and proper insulin release, ultimately improving the care and treatment of diabetic Veterans.